A small calcium-binding protein may be key to stabilizing the sensory hair cell stereocilia Elongation Complex

The purpose of this administrative supplement is solely to request childcare costs as per NOT-OD-25-009.
There are no changes to the work proposed.

Public health relevance
The purpose of this administrative supplement is solely to request childcare costs as per NOT-OD-25-009. There are no changes to the work proposed.